Endothelial Regulation of Astrocyte Trans-Differentiation in Stroke

Neurogenesis plays an important role in stroke recovery. In models of cerebral ischemia, neurogenesis is
amplified in the sub-ventricular zone (SVZ) and the sub-granular zone (SGZ). In addition to these responses in
the standard neurogenic niches, some reports suggest that parenchymal astrocytes may convert into neurons
after stroke. Within neurogenic niches in SVZ and SGZ, brain endothelial cells play a vital role by secreting
trophic factors to support neural stem cells. Is it possible that brain endothelium may also help regulate
astrocyte trans-differentiation? In this proposal, we will investigate this idea, i.e. brain endothelial cells act as
an unexpected source of signals to convert astrocytes into neurons, thus improving outcomes after stroke.
Our pilot data suggest that (i) oxygen-glucose deprivation (OGD)-stimulated brain endothelial cells convert
astrocytes into neural progenitor cells (NPC) in vitro, (ii) transfer of microvesicles derived from OGD-stimulated
brain endothelial cultures reprogram astrocytes into NPC in vitro, (iii) microvesicles derived from OGD-
stimulated brain endothelial cells also convert astrocytes into NPC in vivo, and promote recovery in mouse
focal cerebral ischemia, (iv) pro-neural transcription factor Ascl1 in brain endothelial cells may be involved in
astrocyte trans-differentiation, (v) methods to dissect these mechanisms (mouse genetics, brain endothelial
cell-specific viral infection, lineage tracing, single-nuclei RNA-seq, imaging etc) are feasible in our labs.
Based on our pilot data, we hypothesize that up-regulation of Ascl1 in brain endothelial cell-derived
microvesicles induces astrocyte trans-differentiation, thus contributing to neurogenesis, tissue repair, and
recovery after stroke.
We have 3 specific aims. In Aim 1, we will compare effects of major neurovascular unit cells on astrocyte trans-
differentiation. In Aim 2, we will dissect mechanisms of brain endothelial cell-mediated astrocyte trans-
differentiation, and use gain- and loss-of-function experiments to manipulate Ascl1 expression in brain
endothelial cells, and track astrocyte trans-differentiation after focal ischemia. In Aim 3, we will investigate the
effect of microvesicles derived from Ascl1-overexpressed brain endothelial cells on astrocyte trans-
differentiation, and assess neurogenesis, tissue repair, and sensorimotor/cognitive outcomes in young, older,
male or female mice after focal ischemia. Our experiments will utilize mouse genetic and molecular tools
including a combination of AAV-induced brain endothelial cell-specific gene expression (Tie2-Cre or Cdh5-Cre
mice), lineage tracing of astrocytes by using tamoxifen-inducible Aldh1l1-CreERT2;R26R-YFP mice, scRNA-
seq or snRNA-seq to fully map transcriptomes of astrocytes in mice treated with microvesicles post stroke.
Translational relevance will be assessed with in vivo optical imaging and long-term outcomes post-stroke. This
project should define a new form of endothelial signaling in stroke, identify a unique vascular-regulated
mechanism of neuroplasticity, and hopefully may lead to novel therapeutic opportunities for brain repair.

Public health relevance
Project Narrative: Endothelial regulation of astrocyte trans-differentiation in stroke The generation of new brain cells called neurons (i.e. neurogenesis) plays an important role in stroke recovery. Here, we will investigate a novel phenomenon whereby cells from blood vessels in the brain (i.e. brain endothelium) can release unexpected molecular signals that convert a different type of brain cell called astrocytes into newborn neurons, thus augmenting neurogenesis and improving functional outcomes after stroke. Understanding the mechanisms of this new blood vessel-regulated phenomenon of neurogenesis may open up new opportunities for pro-recovery therapies in stroke patients.